Impact of Early-life Exposure to Semi-Volatile Organic Compounds (SVOCs) on Neonatal and Early Childhood Immune Function

Project Summary
The immune system plays a critical role in maintaining a child’s health, and immune
deficits may have serious consequences ranging from increased susceptibility to infections to
allergic and autoimmune conditions. Although many factors contribute to overall immune health,
emerging data suggest that early life environmental exposures interfere with immune
development and function. Identifying modifiable environmental factors that affect children’s
immunity, our overarching goal is critical to reducing infant morbidity and mortality and has long-
term implications for improving health.
Semi-volatile organic compounds (SVOCs), including organophosphate esters,
phthalates, pesticides, and flame retardants, are used in consumer and personal care products,
electronics, furniture, and building materials. As a result of their extensive use and environmental
persistence, SVOCs are detected with high frequency in indoor environments, and human
exposure to mixtures of SVOCs is widespread. Our proposed research assesses exposure to
SVOC mixtures throughout pregnancy and in infancy. We will investigate individual characteristics
associated with higher levels of exposure and evaluate the potential for adverse health outcomes
among exposed women and their children.
Animal studies provide compelling evidence that exposure to individual SVOCs impacts
immune function; however, the extent to which these studies extend to human populations is
unclear, particularly because they largely consider exposure to single chemicals, which does not
reflect real-world exposures (i.e., those occurring in mixtures). Our primary objective is to
investigate the impacts of early life exposure to SVOC mixtures on children’s immune function,
and in doing so, to fill a critical gap in the understanding of the impacts of SVOCs. This study will
be the first to evaluate the role of SVOC in altering the protection of the neonate by evaluating
the two most critical aspects of early life immune function: 1) passive transfer of immunity and 2)
the capacity to respond to a novel pathogen-associated antigen. We will capitalize on the
infrastructure of HOPE 1000, an ongoing cohort study with longitudinal collection of SVOC
exposure monitors during each trimester of pregnancy and in early childhood, and the
biospecimen needed to evaluate immune function and pathogen immunity.
Identifying specific SVOCs or mixtures of SVOCs that affect immunity may provide new
opportunities for interventions at the individual and policy levels. Such data are critically needed
as the use of some SVOCs is predicted to increase in the coming years.

Public health relevance
Project Narrative Semi-volatile organic compounds (SVOCs) are ubiquitous environmental contaminants, and human exposure is widespread. We will investigate whether early-life exposure to SVOCs adversely affects children’s immunity to common pathogens. Identifying modifiable environmental factors that influence the development and function of the immune system has long-term implications for improving health.